PREVALENCE OF URINARY TRACT INFECTION

To try to determine the prevalence of UTI in febrile infants regarding the source of the fever. An epidemiology survey of all febrile infants who seek medical care at Children's hospital.